The Role of TREK-1 potassium channels in ARDS

PROJECT SUMMARY:
Significance: To date, no targeted therapies exist that prevent or improve the outcomes of patients with
Acute Respiratory Distress Syndrome (ARDS). Despite an increasing awareness of hyperoxia (HO)-induced lung
injury and low tidal volume mechanical ventilation (MVL) strategies, mortality rates have plateaued at 35-45%
causing 75,000 deaths/year, and suggesting that we may have maximized the therapeutic potential of these
standard interventions. Additionally, progress in this field is hindered by the technical difficulties in experimentally
replicating the inflammatory environment at the alveolar-capillary interface with current ARDS models. Therefore,
the identification of molecular targets, and the development of new therapeutic strategies and improved ARDS
models represents a high priority topic with substantial impact in Pulmonary and Critical Care Medicine.
In search for new therapeutic approaches, the Schwingshackl laboratory discovered epithelial TREK-1 K+
channels as key regulators of alveolar inflammation using simple, one-hit HO- and Influenza-A virus (IAV)-
induced lung injury models. However, the importance and protective potential of TREK-1 K+ channels in clinically
more relevant triple hit (IAV+HO+MVL) ARDS models remains unknown.
To bridge these knowledge gaps and advance the field in a new direction, based on strong and exciting new
preliminary data the authors now hypothesize that (i) ARDS decreases epithelial and endothelial TREK-1 levels,
which causes cell membrane depolarization and subsequently promotes Ca2+-dependent alveolar inflammation,
and (ii) this injurious cascade can be counteracted by activation of the subset of residual TREK-1 channels.
Using IAV as the most common ARDS trigger worldwide (besides SARS-CoV-2), and clinically-relevant HO
and MVL strategies, Aim 1 will investigate whether IAV, alone and combined with HO/MVL, decreases epithelial
and endothelial TREK-1 levels, and thus accelerates further lung injury. Aim 2 will determine whether activation
of the subset of residual TREK-1 channels can protect against IAV-induced ARDS. Aim 3 will establish the
molecular signaling mechanisms and protein-protein interaction networks underlying TREK-1-mediated
protection, by using high-throughput electrophysiological approaches and precision medicine Functional
Enrichment Analysis tools, to ultimately facilitate rational drug design. For these studies, the authors will utilize
novel and complementary pharmacological and genetic loss- and gain-of-function approaches, including newly-
developed TREK-1 activating compounds (ML335, ML6733, BL1249), targeted cell type-specific TREK-1
overexpressing and TREK-1 KO mouse models, primary human alveolar epithelial/endothelial cells and lung
tissue, and two next-generation experimental ARDS models (Bioreactor; modified microfluidic SynVivo platform).
Potential for high Impact: (i) Establish aberrant TREK-1 signaling as an unrecognized pathway in ARDS;
(ii) highlight TREK-1 activation as a novel therapeutic target for rational drug design; (iii) introduce two novel
experimental ARDS models to study injurious events at the notoriously challenging alveolar-capillary interface.

Public health relevance
PROJECT NARRATIVE: Acute Respiratory Distress Syndrome (ARDS) is a devastating illness most commonly caused by viral infections, and Influenza-A virus (IAV) alone accounts for 300,000-500,000 annual deaths worldwide. Our strong and exciting preliminary data support the hypothesis that epithelial and endothelial TREK-1 potassium channels are downregulated in ARDS lungs, and this injurious process can be counteracted by pharmacological activation of the subset of residual TREK-1 channels with newly-developed compounds. In this proposal we will explore the potential of TREK-1 channels as novel targets against IAV-induced ARDS by establishing (i) the importance of ARDS-induced TREK-1 deficiency in the development of lung injury, (ii) the potential of TREK-1 enhancement as a novel protective strategy, and (iii) the molecular signaling mechanisms underlying TREK-1 protection to facilitate future rational drug design.